Transformative Solutions for Reducing Frequent 911 Fall Calls in the Homes of Patients with Cognitive Impairments

PROJECT SUMMARY
There is a global upsurge of falls in older adults that impacts nearly every family across the world. Millions of
older adults fall each year in the United States, leading to catastrophic injuries, deaths and soaring healthcare
costs. Over the last decade, 911 fall calls have tripled while transport rates to the hospital after a fall have
significantly decreased. Instead, 911 is increasingly used for lift assists (falls that do not result in transport).
Deployment of emergency medical services for lift assists diverts care from higher acuity emergencies and costs
more than 200 million dollars annually in the United States. There is a potentially powerful yet underutilized
solution if we leverage the hidden opportunities of fall events, such as lift assists that do not result in catastrophic
consequences, to activate prevention strategies. This study aims to develop a scalable strategy for early
identification of individuals at high risk of falls and activate prevention solutions. We hypothesize that a systematic
911 fall call intake which has a broader concept of frailty, Frailty And Cognition+Environment (FaCE), will better
account for the compounding and cascading nature of fall risks in older adults. At the completion of this project
a scalable machine learning model which incorporates FaCE factors to predict high utilization of 911 for falls will
be developed. In addition, we will characterize barriers and facilitators for adoption, implementation, and
maintenance of fall prevention strategies in the home for patients with FaCE risk factors. This project will utilize
a blend of systems science and community-based participatory research approaches and state of the art
predictive analytics to elucidate the FaCE of falls, develop a scalable fall prevention solution that can be
implemented nationwide and inform a larger-scale implementation trial for using 911 fall calls to activate effective
fall prevention strategies in homes.

Public health relevance
PROJECT NARRATIVE Healthcare costs for falls have reached 55 billion dollars annually in the US with falls in older adults impacting nearly every family, in every sector, of every community. Leveraging 911 fall calls as activation events could transform our ability to identify high risk individuals and significantly impact fall prevention strategies. At the completion of this study, a scalable EMS fall prediction tool will be developed to elucidate the impact that frailty, cognitive impairment and the home environment have on emergency fall events in order to activate and transform effective fall prevention solutions in the homes of vulnerable older patients.